CCSS Expansion Study Supplement

ABSTRACT
The Childhood Cancer Survivor Study (CCSS) is a multi-institutional, multi-disciplinary collaborative research
resource established to systematically evaluate long-term outcomes among children diagnosed with cancer who
survived five or more years from diagnosis. With the successful recruitment and longitudinal follow-up of the
cohort that includes survivors diagnosed and treated over three decades (1970-1999), the CCSS is the world’s
largest established open resource for survivorship research with 38,036 eligible survivors available for
investigation of late mortality, and 25,665 participants who have contributed health-related and quality of life
outcomes. The resource includes comprehensive annotation of treatment exposures, ongoing longitudinal
follow-up and an established biorepository from which genotype (SNP array) and DNA sequencing of 8,380
survivors are available to investigators for identification of genetic susceptibility for disease- and treatment-
related late effects. Radiation therapy (RT) has substantially evolved over the past two decades since the
establishment of the CCSS cohort. As opposed to previous CCSS methods which required paper copies of RT
planning documents for review by the CCSS Radiation Dosimetry Center at MD Anderson, data from modern
RT planning, collection and processing multi-institutional RT DICOM data spanning two decades will require a
new and robust infrastructure. In this pilot study, we propose to collect and process 100 radiotherapy records
from each of five representative CCSS institutions with the aim of a developing and testing a standardized data
collection and processing methodology for use in a future CCSS expansion.

Public health relevance
Survival rates for many childhood and adolescent cancers have improved at a remarkable pace over the past five decades. The CCSS cohort has been the source of some of the most significant publications to date addressing the long-term mortality, morbidity and quality of life of survivors of childhood cancer. Understanding the risk for late effects of childhood cancer and its therapy provides the basis for health screening recommendations and interventions that can mitigate long-term health problems in this high-risk population.